Clinician-Scientist Research Education and Training in Otolaryngology

PROJECT SUMMARY
The primary goal of the Research Education Program in the Department of Otolaryngology-Head and
Neck Surgery (OtoHNS) at the University of Washington (UW) is to provide every resident in our department
with knowledge, skills, and inspiration to establish an independent and sustainable research program in an
academic setting as a Clinician-Scientist. We also offer research training and education to medical students to
encourage them to pursue academic careers in Otolaryngology. The long-term goal of our program is to
increase the research contributions of Otolaryngologists and to hasten development of better treatment options
for patients with disorders impacting communication.
Our research training program has had outstanding outcomes under support of a NIDCD T32 Grant for
40 years. For example, 64% of the resident Participants in the past 15 years are in full-time academic
positions. To continue these efforts, we request support for five Postdoctoral (resident) Participants and
one Predoctoral (medical student) Participant. The OtoHNS Department contributes funds for this training
and also offers 1-2 years of Post-Residency Fellowship to one resident in our Program to continue mentored
research training, prepare a K Award application, and gain additional clinical training. We are dedicated to
training diverse Participants. We evaluate Program outcomes using input from Participants, Preceptors, and an
Advisory Board, and we use feedback to build best practices and meet the changing needs of Participants.
We propose two major aims: mentored research training (Aim 1) and structured research
education (Aim 2). For Aim 1, every resident receives intensive research training with an experienced, well-
resourced Preceptor for 80% of their working hours during a one-year or two-year period, starting in the third
year of residency. Before this, residents select a Preceptor, either amongst the 23 Preceptors we describe or
another Preceptor who fits our strict criteria. Together, they define a research project and a training plan.
During the R25-funded year(s), Participants conduct research in their Preceptor’s group, learning the critical
skills needed for research success. Concurrently, residents attend structured research educational
sessions (Aim 2) with OtoHNS faculty and Program Alumni who impart key research skills and provide
guidance for career development in academic Otolaryngology. Residents spend 20% of the R25 year(s) in
clinical training. After the R25-supported time, residents continue research activities, facilitated by a
department-supported research rotation with minimal clinical activities. Medical student Participants engage in
the same mentored research and educational elements as residents for 9 months, working closely with them.
Our Program prepares Participants at both levels for successful careers in academic medicine.

Public health relevance
PROJECT NARRATIVE We propose a new program for Clinician-Scientist Research Education and Training in Otolaryngology at the University of Washington (UW). We provide structured and rigorous education to residents and medical students on how to conduct innovative and impactful research in several areas relevant to communication, including hearing, speech, language, balance, smell, voice, airway, and head and neck cancer. Our program combines intensive mentored research training, coursework, and workshops, plus instruction on professional development toward an academic career.